MULTICENTER GLYCOSYLATED RECOMBINANT HUMAN INTERLEUKIN 6 IN PATIENTS

This project evaluates the safety and efficacy of the medication recombinant human interleukin in patients with solid tumors undergoing intensive antitumor therapy with chemotherapy.